Core-006

The Center for Clinical and Translational Science and Training (CCTST) must have adequate support of
diverse network-wide activities to facilitate success in clinical and translational research. Our last competing
renewal contained a Network Resources section for the first time, as well as Optional Functions. With regard to
Optional Functions, we submitted: 1) Acute Care Research; and 2) Lifespan Data Integration. For Network
Resources and Multi-Site Study Support, we focused on local investigator support for multi-site trials via our
two Clinical Trial Offices (CTOs), since the Trial Innovation Network (TIN) had not yet been formed. In this
competing renewal, CCTST 3.0, we continue to support local multi-site investigators in the same fashion, with
some significant changes underway to improve CTO services across the Academic Health Center (AHC). In
addition, we have a fully functional TIN Hub Liaison Team and have had increasing collaboration with the TIN.
We now have two local investigators receiving TIN services and are continuing toward our participation in TIN
trials. We intend to further increase AHC-wide collaboration in support of multi-site human subjects research.
We have operationalized the Acute Care Research Core as a permanent feature of the CCTST. This builds on
the success of the Acute Care Research optional function to date, leverages our many unique strengths in
acute care research, and highlights the importance of acute care research within our AHC. We will adopt the
guiding principles of Learning Health Systems applied to continuous improvement of our Network Resources
described herein, along with close collaboration with the other CCTST cores. We will 1) engage stakeholders
in meaningful multi-site clinical research, including further involvement in TIN studies; 2) continue to develop a
multidisciplinary workforce with expertise in multi-site research, especially acute care research; and 3) optimize
the use of biomedical data in support of all aspects of clinical research locally and nationally.